The role of tetraspanin-regulated endolysosomal trafficking in Alzheimer's Disease

Although the accumulation of Aβ and subsequent chronic inflammation and neuronal
dysfunction likely contribute to the development of Alzheimer’s disease (AD) pathology and clinical
manifestation, the mechanisms for AD initiation and progression in sporadic, late-onset cases
remain unclear. An abundance of pathological and genetic evidence points towards a role of the
endolysomal network and its effects on APP trafficking and processing as a potential initiator of the
disease.
We recently found that tetraspanin CD151 restrains the releases of i) APP, ii) α-secretase,
and iii) pro-inflammatory molecules. Our recent studies also show that CD151 sustains proper
structure and function of endolysosomes, e.g., supporting proper turnover of proteins in
endolysosomes. These observations underline a putative mechanistic connection between
dysregulated endolysosome function, resulting from the diminished CD151 level in inflammation
and aging, and abnormal processing of APP, leading to chronic inflammation and AD. This notion
forms the basis of our hypothesis for this research project, i.e., CD151-dependent endolysosome
trafficking is required for proper degradation and limited release of APP.
The goal of this project is to understand the mechanistic roles of CD151-regulated
endolysosomal proteolysis in the pathogenesis of AD. Specifically, we will assess both in vitro and
in vivo effects of CD151 removal on the i) endolysosomal trafficking and/or processing of APP and/or
its relevant secretases, ii) secretion of pro-inflammatory molecules, and iii) AD-related pathological
and behavior changes.
From these in-depth mechanistic studies, we will understand if and how CD151-dependent
regulation of endolysosomes is important for the progression of AD, likely establish a novel
paradigm between molecular identity of endolysosomes and proteolytic determination of APP, and
possibly delineate the molecular switch that governs the Aβ deposition in brain. At the end of this
project, we will develop an integrated understanding of the unique features of endolysosome and
tetraspanin CD151 in the pathogenesis of AD, which will ultimately lead to the development of
therapeutic strategies against AD.

Public health relevance
Project Narrative Alzheimer’s disease becomes a leading cause of the death for aged people in developed countries, and understanding the progression of Alzheimer’s disease is crucial for finding the cure for this disease. In this project, we will determine how a transmembrane protein called CD151 regulates the progression of Alzheimer’s disease. Our study will also provide insight into the general mechanisms that govern the brain inflammation and identify promising candidates to combat degenerative diseases and chronic inflammation of brain.